Predicting context-specific molecular and phenotypic effects of genetic variation through the lens of the cis-regulatory code

ABSTRACT
A central challenge in human genomics is to interpret the regulatory functions of the noncoding genome, and to
identify and interpret variants with regulatory functions. In this project we plan to leverage recent advances in
experimental functional genomics (including single cell methods and high throughput perturbation methods)
alongside recent progress in deep learning models of gene regulation, to make fundamental progress on these
problems. We have assembled a team of investigators with diverse and complementary expertise – in deep
learning, single-cell genomics, cellular QTLs and GWAS, and high throughput validations – to build, test, and
implement predictive models for interpreting disease associations. Specifically, we aim to (1) Develop
interpretable base-resolution deep-learning models for regulatory sequences; (2) Predict and validate cell type-
specific effects of regulatory variants on molecular phenotypes and disease; (3) Collaborate with the IGVF
Consortium to build nucleotide-level regulatory maps. Our ultimate goal in this project will be to create a
nucleotide-resolution cis-regulatory map of the human genome to connect disease variants to functions and
phenotypes, in diverse cell types, states, and spatial contexts.

Public health relevance
PROJECT NARRATIVE The purpose of this project is to create a nucleotide-resolution cis-regulatory map of the human genome to connect disease variants to functions and phenotypes, in collaboration with the IGVF Consortium. We will use our new methods to help interpret common and rare genetic variation, and to identify variants that may contribute to disease. Outputs from the project will include new computational methods, open-source software, and publicly available cis-regulatory maps for diverse cell types.